STRESS &PREVENTION OF HYPERTENSION IN AFRICAN AMERICANS

The purpose of this study is to determine the efficacy of stress reduction for the primary prevention of hypertension in high risk African Americans with high normal blood pressure.